Remmie.ai: a deep learning diagnostic assistance engine for ear-nose-throat diseases

PROJECT SUMMARY
Otitis media (OM) is experienced by five out of six children before their third birthday, and 30-40% suffer
recurring infections, leading to 16 million annual episodes in the US. Ear infections are the primary reason for
antibiotic prescription for children under 6 years, are the second most common cause of hearing loss, and can
lead to lifelong sequelae. Diagnosis depends upon in-person clinic visits and visual examination by care
providers, at great inconvenience to patients and caregivers and at significant cost to the healthcare system,
estimated at $4 billion per year. Although the majority of OM cases resolve within a week and symptoms may
be managed by over-the-counter medications,10-20% do not, requiring additional antibiotic treatment or, in
extreme cases, tympanostomy tube insertion to provide ventilation to the middle ear and aid in fluid drainage.
Another compounding factor is limited access to otolaryngologists for accurate diagnosis and infection
management. The expansion of telehealth has the potential to address this need with rapid, convenient, and
affordable, but to date, there are no platforms to support and facilitate effective virtual visits for OM diagnosis.
The first Specific Aim of this Phase I proposal involves building a comprehensive database of several thousand
images of eardrums from patients with or without acute OM, with associated clinical diagnostic labels to, in
Specific Aim 2, train a novel custom machine learning algorithm, Remmie.ai. A convolutional neural network
will be developed to classify images of eardrums paired with text description of symptoms. Image classification
will be improved through data augmentation, and the custom Remmie.ai architecture built through transfer
learning of a publicly available training model. Unblinded labels will be compared to the algorithm readout as
blinded testing data are loaded into Remmie.ai to ensure convergence of accuracy and validation for
classification of acute OM versus normal eardrums. In Specific Aim 3, the Remmie.at platform, coupled with a
handheld “portable otoscope” for imaging patients’ eardrums and a user-friendly mobile device application, will
be tested by end-user physicians to derive feedback on the usability of the device and software. The outcome
will be a novel tool for both patients and caregivers to monitor otolaryngic diseases, specifically acute OM,
based on patient-provided images and symptoms, and diagnosis, aided by the proprietary Remmie.ai
algorithm.

Public health relevance
PROJECT NARRATIVE Every year, millions of children and adults in the US and around the world suffer from otitis media, or ear infections, resulting in a dramatic healthcare and economic burden, and potential recurrence and long-term disability. Numerous complications to diagnosis and treatment exist, including patient vulnerability, the requirement for visual examination, and limited access to otolaryngologists. The Remmie.ai platform addresses this need by providing an at-home system to accurately capture ear infection symptoms and images, precisely recognize infection through a machine learning-based diagnostic support algorithm and connecting users with telemedicine providers for rapid treatment options.